Printed Electronic Biosensors for Point-of-Care Testing of Cardiovascular Biomarkers

ABSTRACT
Heart disease is the leading cause of death in the United States, claiming over 600,000 lives annually. The
measurement of blood-based biomarkers to narrow differential diagnoses and triage patients plays a critical role
in the management of acute and chronic cardiovascular disease. This R01 project will develop a handheld point-
of-care test (POCT) that uses low-cost, disposable assay cassettes to measure multiplexed panels of cardiac
biomarkers directly from a drop of whole blood. The assay brings together major advances in carbon nanotubes
(CNTs) integrated into thin-film transistors (CNT-TFTs) and an assay platform (called “D4”) for detecting protein
analytes with ELISA-like performance from a single drop of blood. Both the CNT-TFTs and D4 are fabricated by
printing, making them readily customizable and low cost. CNT-TFTs offer extremely sensitive nanotubes for
electrical transduction in an assay and, unlike prior CNT-based biosensors, the CNT-TFTs provide reproducible
performance and high yield. The D4 is a fluorescence-based assay that uses antibody (Ab) pairs printed into a
polymer brush coating (“POEGMA”) that eliminates background noise and permits highly sensitive
measurements directly in complex biological milieu. Merging these two innovative technologies leads to the “D4-
TFT”, which combines the electronic sensitivity of the CNT-TFTs with the nonfouling selectivity of the D4 to yield
an assay that can rapidly detect biomarker concentration from whole blood without rinsing, via electrical
transduction. Extensive preliminary data demonstrate the D4-TFT’s fully printed fabrication, preservation of
transistor operation, and successful detection of target analytes from serum and blood. The specific aims of this
project include the development of a handheld POCT unit, with all needed control electronics and a simple user
interface with display, and adaptation of the D4-TFT to compatible cassettes that are inserted into the handheld
unit for operation. Analytical performance of the D4-TFT assay will be maximized and multiplexed against two
panels of cardiac biomarkers: (1) A panel of validated cardiac biomarkers that includes creatine kinase (CK),
CKMB, troponin (Tn), and N-terminal pro b-type natriuretic peptide (BNP), which are central to the diagnosis and
management of a wide spectrum of cardiovascular conditions, including acute chest pain, myocardial infarction,
and heart failure (HF); and (2) two investigative cardiac biomarkers, angiopoietin 2 (ANG2) and tumor necrosis
factor alpha (TNFα), which are of major interest for their potential association with bleeding events in advanced
HF patients with left ventricular assist device (LVAD) implants (the most common complication in this population).
These two diverse panels of cardiac biomarkers will demonstrate the versatility and value of this POCT, both for
diagnostic potential using validated biomarkers as well as for rapid clinical screening of investigative biomarkers.
Accomplishing these aims will lead to a novel POCT for cardiac biomarkers that can be scaled up easily. Its fully
printed nature makes the D4-TFT highly customizable and broadly applicable to other blood-based tests for any
biomarker with immunoassay reagents.

Public health relevance
PROJECT NARRATIVE The measurement of cardiovascular biomarkers is a critical component in the care of patients with various cardiac problems, but this can be greatly improved if these tests could be performed at the point-of-care, even outside of hospital settings. The proposed research will develop a handheld point-of-care test with low-cost, disposable cassettes that are fully printed and capable of multiplex detection of cardiac biomarkers from a single drop of whole blood. Clinical evaluation will be carried out with this handheld system to demonstrate its ability to diagnose cardiovascular disease compared to gold standard tests.